Spatial and Temporal Correlates of Specific Cause Mortality

Revised Project Summary. This project will create two specialty homicide databases in the United States (2000-2018) using resources previously developed. These specialty homicide data will be merged with several unique public data sources that collect information on local crime statistics, other measure of the local environment, and socio-demographic Census data. This specialty database can then be used by the project team and other researchers to test the correlates of certain types of homicides. Homicide is a major source of mortality for adolescent and young adult men and is therefore a major public health issue. This project will also create a GIS database which geo-codes certain types of homicides for other researchers to study the independent effect of these homicides on population health, health disparities, and community well-being.

Public health relevance
Revised Project Narrative. Our project will build a database of selected types of homicides that have occurred from 2000 to the present. We will compile nearly two decades of selected types of homicide data in the United States to test heretofore untested hypotheses regarding the causes and effects of these homicides, a widely recognized public health problem with potentially far-reaching community effects. First, we will create a specialized homicide database to test the correlates of homicides. Second, we will create a geodatabase that spatially pinpoints all selected types of homicides that will allow for the study of the effect of these homicides on population health and community well-being. Third, we will examine relationships between local and contextual factors, and certain key types of homicide.